First in Class Mitochondrially targeted antioxidants with transcriptional modulator capabilities and their implication in the diseases of the eye

Dry Eye Disease (DED) affects 20% of the global adult population, with higher rates in developed countries like
the USA. It significantly impacts quality of life, productivity, increases healthcare costs, and can lead to vision
loss if untreated. Current therapies are incapable of addressing chronic DED as they cannot be used long-term
due to their toxicity. Our innovative First-In-Class mitochondrial technology targets the root cause of DED by
addressing oxidative stress and mitochondrial dysfunction, which induces Meibomian Gland Dysfunction (MGD),
a predominant cause of DED. Due to its unique mechanism of action, our drug candidate is safe for long-term
use and offers a broader therapeutic window. This noninvasive treatment promises to revolutionize eye care and
provide a sustainable solution to this widespread health challenge.
Our proprietary small molecule lead candidate exhibits dose dependent free radical scavenging potential with
calculated IC50 of 2.1µM and was found to protect various ocular cell lines against oxidative stress. It was found
to be highly efficacious in reducing Benzalkonium chloride induced dry eye, tissue damage and vascularization
in mice model of dry eye. An ophthalmic safety study suggests that an acute TID dose of our candidate as eye
drops up to 30 µg/eye (total dose of 90 µg/eye/day) was well tolerated in New Zealand White rabbits.
We have secured our invention by the filing of patent applications in the USA (US2021163159081), China
(CN2280008594), India (IN202317001652), Canada (CA3205099A1), EU (EP22767950.3), Brazil (BR
1120230181097), Australia (AUS 2022234307) and Japan (JP2023-555226) for compounds, compositions, and
their method of use. The novelty of our invention is confirmed by a written opinion from USPTO and an enhanced
freedom to operate searches by qualified patent attorneys.
DED is a multifactorial indication; therefore, in proposed SBIR phase I, our proposed studies entail In vivo
characterization of lead candidates in desiccating stress/scopolamine (DSS) model of DED in mice working
through varied etiologies. We also propose to evaluate the toxicity of our lead in repeated dose 7-day rabbit
model of toxicity with PK parameters and local biodistribution in eye tissues of rabbits. Successful completion of
proposed studies will be followed by submission of a phase-II SBIR to conduct a set of IND-enabling pre-clinical
studies, manufacturing process scaleup and development, and analytical method validation, GLP toxicity studies
with recovery group. Setup of in-house eCTD software interface and electronic submission gateway (ESG) with
FDA and relevant certifications of personnel and workstation infrastructure will also be included in the SBIR
phase-II application. We have assembled an experienced team consisting of chemists, drug discovery and bench
to bedside drug product development experts, pharmacologists, ocular pharmacokinetics, toxicologists,
ophthalmologists, regulatory experts, and industry partners. We are confident of successfully completing the
proposed work.

Public health relevance
Reactive oxygen species (ROS)-mediated oxidative stress drives both upstream and downstream mechanisms of dry eye disease (DED), leading to mitochondrial dysfunction, inflammation, and glandular damage. Our drug candidate directly targets ROS-induced mitochondrial dysfunction, addressing the root cause and interconnected pathways of these debilitating conditions. This First-in-Class therapy offers a transformative solution with the potential to redefine the standard of care for DED and other ocular diseases, providing hope for millions of underserved patients.